Shaping Cardiac Immuno-metabolic Homeostasis by the Lysosome

PROJECT SUMMARY
Heart failure with preserved ejection fraction (HFpEF) accounts for half of the heart failure hospitalizations in the US
thus representing a major public health priority. However, currently, there are limited effective approaches to
preventing and managing this complex syndrome. Systemically, obesity-associated hyperlipidemia,
hyperglycemia, and chronic inflammation have been considered as the major factors for the pathogenesis of HFpEF.
In the heart, maladaptive cardiac immuno-metabolic reprogramming is a hallmark of HFpEF. In cells, nutrient
sensing, macromolecule catabolism, and inflammatory regulation are fine-tuned by the lysosome. However, the
extent and mechanisms by which lysosomal dysfunction contributes to the pathogenesis of HEpEF are poorly
defined. The objective of this proposal is to determine the pathophysiological impact of cardiac lysosomal
dysfunction in the setting of HFpEF. The lysosome contains more than 70 enzymes. As such, murine studies of
individual lysosomal enzymes have contradicting observations regarding cardiac pathophysiology. Lysosomal
reductase Gamma Interferon-Inducible Thiol Reductase (GILT) is the only identified lysosomal reductase that
controls diverse sets of lysosomal enzymes and cargoes. We found that GILT is reduced in the hearts of humans
with HFpEF and obese mice, respectively. Notably, both lean and obese mice with a human GILT SNP for CVD
risk displayed a significantly reduced diastolic function without other interventions. Furthermore, loss of GILT in
cardiomyocytes accelerates the HFpEF-related cardiac decline. Transcriptomic and metabolic analyses further
revealed that cardiac GILT deficiency disrupted the immuno-metabolic homeostasis in the heart. Therefore, we
hypothesize that GILT protects against cardiac immuno-metabolic imbalance in obesity-associated HFpEF.
We will pursue two specific aims to test this hypothesis. In Aim 1, we will investigate the pathological significance
of cardiac GILT in the context of HFpEF by using novel gain- or loss-function of GILT mouse lines. In Aim 2, we
will elucidate molecular mechanisms for cardiomyocyte GILT-regulated mitochondrial function, glucose
homeostasis, and inflammasome activation. To answer these challenging questions, we have assembled a
strong collaborative team. Each co-PI is a recognized expert in her/his respective field (organelle functions in
obesity, cardiac pathophysiology, and cardiac metabolism). This collaborative research proposal is innovative,
combining the use of cellular and molecular approaches, metabolomic analyses, as well as in vivo mouse
metabolic and cardiac profiling. Findings from this study will provide insights into interplays between cardiac
lysosomes, inflammatory responses, and metabolic homeostasis and should speed the development of novel
therapies for improving cardiovascular health.

Public health relevance
PROJECT NARRATIVE: Heart Failure with Preserved Ejection Fraction (HFpEF) encompasses approximately half of all heart failure cases. The proposed project is relevant to public health in that it is expected to reveal a novel molecular mechanism that underlies the impact of defective cardiac lysosome-governed immune-metabolic adaptation contributes to the progression of cardiac dysfunction during HFpEF, and to thereby advance knowledge in the fields of cardiovascular diseases. Thus, the proposed research is relevant to the NIH mission of developing fundamental knowledge that will help to reduce the burdens of human disability.